Increasing Breast Cancer Screening in Chinese Immigrants

In New York City (NYC), persons of Chinese descent experience the highest cancer mortality rate of any ethnic
group. Breast cancer is the most commonly diagnosed cancer in Chinese immigrant women, who experience
substantial increases in breast cancer risk after spending a decade or more in the US. Regular mammography
screening and timely follow up are crucial for early detection of breast cancer and increased survival. However,
Chinese immigrant women in NYC report low utilization of screening mammography and are less likely to
complete follow up in a timely manner compared to non-Latina white women. Chinese immigrants in NYC are
more likely to live below the poverty line, to lack insurance, and to be without a usual source of care. Over 50%
have less than a high school education, cannot speak or understand English, and would not see a western
doctor as a first course even if they had symptoms. Research within this community has revealed that only
23% of Chinese immigrant women in NYC had ever had a mammogram in their lifetime. This is a population
with great need for basic medical care, increased breast cancer knowledge, and access to breast cancer
screening. Health disparities plague the health care system and arise from a complex interplay of economic,
social, and cultural factors. The Health Belief Model (HBM) provides a framework for addressing cultural health
disparities related to preventive health care and cancer screening by positing that making a decision to engage
in a health behavior is determined by weighing perceived threats versus benefits. Guided by the HBM, the
Witness Project uses narrative communication (e.g., storytelling, personal testimonials) to educate, persuade,
and engage target communities about cancer prevention and screening. Our work in minority and immigrant
communities has demonstrated that narrative communication can increase participation in breast cancer
screening. However, the efficacy of these interventions has not been empirically tested among Chinese
immigrants. The long-term goal of the proposed line of research is to increase breast cancer screening rates
for NYC Chinese immigrants. We plan to accomplish this objective by pursuing the following specific aims: AIM
1. Culturally and linguistically adapt the Witness Project, a narrative breast cancer education program,
for Chinese immigrant women. Focus groups and qualitative interviews will be conducted with community
gatekeepers and stakeholders to obtain feedback on intervention content. AIM 2. Pilot test feasibility and
acceptability of WP for Chinese immigrant women. Feasibility and acceptability of the pilot intervention will
be assessed to determine effect sizes for a future large scale trial. Screening mammogram receipt and
intentions to undergo mammography, as well as other HBM constructs will be compared in a pre-post design
stratified by language. Successful completion of the study aims will make a novel and transformative
contribution to the field of cancer screening, especially for this underserved population.

Public health relevance
Chinese immigrant women in NYC report low utilization of screening mammography and are less likely to complete follow up in a timely manner compared to non-Latina white women. Health disparities arise from a complex interplay of economic, social, and cultural factors. We will culturally and linguistically adapt and pilot test an evidence-based, innovative intervention that utilizes narrative communication to address the significant disparities in breast cancer screening in Chinese immigrant communities.